Center for Advanced Imaging Innovation and Research (CAI2R)

Overall Project Summary
The Center for Advanced Imaging Innovation and Research (CAI2R) pursues a mission of bringing people
together to create new ways of seeing. The work of our Center has been focused on creating new paradigms
for the acquisition, reconstruction, and interpretation of biomedical images, and on implementing new
collaboration models in order to translate these developments rapidly into clinical practice.
The world of biomedical imaging is changing, and CAI2R has been at the forefront of that change. Tasks that
were once the sole domain of meticulously-engineered imaging hardware are now beginning to be accomplished
in software, increasingly informed by diverse arrays of inexpensive auxiliary sensors. Information once pursued
through the laborious acquisition of carefully separated image datasets is now being derived from newly
integrated, and richly quantitative, data streams. In keeping with these themes, our Center will be organized
around the following four Technology Research and Development (TR&D) projects going forward:
1. Reimagining the Future of Scanning: Intelligent image acquisition, reconstruction, and analysis.
2. Unshackling the Scanners of the Future: Flexible, self-correcting, multisensor machines.
3. Enriching the Data Stream: MRI and PET in concert.
4. Revealing Microstructure: Biophysical modeling and validation for discovery and clinical care.
In each of these projects, we aim to push medical imaging technology to the next level, both in hardware and
in software. Having made great strides in developing rapid, continuous imaging data streams, we will next aim
to add key new information to those streams, both from physics-driven microstructural modeling and from data-
driven machine learning. Having focused on the development of robust tools for image acquisition and
reconstruction, we will extend the pipeline to image interpretation, using the results of human- or machine-
derived evaluations of image content as feedback for the further improvement of acquisition strategies and
sensor designs. We will also aim to close the loop between diagnostic sensing and therapeutic intervention,
exploring new ways to guide therapy with continuously-acquired information about tissue bioeffects.
Our Center has an explicit translational focus, which is reflected in the day-to-day operation of TR&D projects
as well as in the topics of Collaborative Projects (CPs) and Service Projects (SPs), which are focused on three
general areas of high public health impact: cancer, musculoskeletal disease, and neurologic disease.
In keeping with this translational emphasis, CAI2R is also be driven by an embedded collaboration model in
which basic scientists, clinicians, and industry developers sit down together regularly at the scanners for
interactive technology development and assessment. With early involvement of clinical stakeholders and
industry partners, we aim to make CAI2R technologies widely available, for the advancement of biomedical
knowledge and for the benefit of patients and the physicians who care for them.

Public health relevance
Overall Project Narrative The Center for Advanced Imaging Innovation and Research (CAI2R) develops novel imaging techniques and technologies for the improved diagnosis and management of cancer, musculoskeletal disease, neurological disease and other disorders with a profound impact on human health. By exploiting connections between imaging modalities such as MRI and PET, we aim to advance the fundamental capabilities of each, so as to expand biomedical knowledge and improve the care of patients.